Early onset colorectal cancer: from symptoms to treatment in a large, safety-net cohort

PROJECT SUMMARY (ABSTRACT)
Early-onset colorectal cancer (EOCRC; CRC diagnosed at < 50 years of age) is a known and worsening public
health problem, with alarming increases in incidence across the US, further complicated by lack of healthcare
access and poor outcomes among racial and ethnic minorities. Diagnosis for younger patients must rely on
symptomatic presentation or another trigger, as routine screening is not recommended for them.
Asymptomatic triggers for CRC testing are family history of CRC, precancerous polyps, genetic predisposing
syndrome, inflammatory bowel disease, but these represent a small proportion of cases. A much larger
proportion of cases have patient report of “red-flag” symptoms (rectal bleeding, abdominal pain, unintentional
weight loss, constipation/diarrhea, or iron-deficiency anemia). However, even in the presence of these
symptoms, factors at multiple levels contribute to delayed diagnosis: low physician suspicion of cancer, failure
to recognize concerning symptoms, overlap of symptoms with other benign disorders, and patients’ lack of
knowledge about the disease. Consequently, younger patients are more likely to be misdiagnosed, experience
diagnostic delays, report longer duration of symptoms prior to testing, and be diagnosed at later stages. To
facilitate earlier diagnoses of EOCRC, we need to better understand prevalence of CRC test orders and receipt
for younger symptomatic patients, and explore the association of time-to-testing with cancer diagnoses,
especially among uninsured, underserved, minority patients.
We have a unique opportunity to generate important information about CRC test order and testing in light of
red-flag symptoms among a large and vulnerable group of younger safety-net patients seen in Dallas County’s
Parkland Health system. We will use existing electronic health records data (EHR) for patients aged 40-49
years from the current NIH-funded PROSPR cohort study, and extend it by extracting additional Parkland
EHR data for those aged 18-39 years, to develop a curated comprehensive colorectal timeline file for those in
the “early onset” age range of 18-49. Using data from these under- and uninsured minority patients, we aim to
describe EOCRC symptom burden and healthcare system interactions leading to CRC test order and test
receipt (Aim 1), and explore association of time-to-testing with cancer stage among patients with EOCRC (Aim
2).
Results from this study will generate epidemiologic evidence about CRC testing among younger under- and
uninsured symptomatic patients, with efficiency gained from use of 10 years of data from a current NIH-
funded cohort study and resultant algorithms. Results from this work can guide development of
recommendations generalizable to a diverse group of people, and generate future research questions to
understand appropriate EOCRC screening and follow-up in this vulnerable population.

Public health relevance
Early-onset CRC, which is especially prevalent among uninsured Americans, is difficult to diagnose because routine screening tests are not recommended until age 45 and, even when younger patients report red-flag symptoms for CRC, the symptoms can be misattributed to benign causes and not followed up with CRC testing. No previous study has assessed follow-up with early onset CRC testing for patients reporting red-flag symptoms in a safety-net healthcare system. Our proposed work will expand data from a large NIH-funded safety-net cohort to study CRC test order, testing and cancer diagnoses among patients aged 18-49 who report a red-flag symptom, with the goal to better understand healthcare delivery for EOCRC prevention and control